GU Malignancies Research Program

GENITOURINARY MALIGNANCIES (GU) RESEARCH PROGRAM
PROJECT SUMMARY/ABSTRACT
The Genitourinary Malignancies (GU) Research Program explores fundamental biologic pathways of critical
importance to the development and progression of prostate, renal and bladder cancer, and fosters
translational, investigator-initiated clinical trials to advance therapeutic options for patients with GU
malignancies. The overarching goals of the GU Program are to identify core mechanistic pathways that
mediate the development and progression of prostate, renal, and bladder cancers and to translate such
information to inform and conduct investigator-initiated clinical trials (IITs) that improve patient outcomes. The
program is organized around 3 scientific aims: (1) Discover mechanisms of response and resistance to existing
and emerging therapies for prostate and renal cancer, (2) Develop novel biomarkers for early detection,
prognosis, therapeutic and clinical outcomes across GU malignancies, and (3) Ascertain the
immunomodulatory environment of renal cell carcinoma and bladder cancer and develop novel
immunotherapeutic clinical trials. The aims and the disease-focused nature of the GU Program allow for multi-
disciplinary investigations that are highly mechanistic, translational, and clinically focused. These aims reflect
major working groups and initiatives that coalesces program members with other cancer center investigators
through inter-programmatic collaborations that result in preclinical and clinical research efforts, grants, and trial
protocols. Extensive use of Case CCC shared resources, specifically, Biostatistics, Cytometry, Imaging,
Athymic, and Translational Research facilitate all aspects of member discoveries.
Under the leadership of Brian Rini (Clinical Co-Leader) and Nima Sharifi (Co-Leader) the GU Program has 28
members including 14 full, 3 associate, and 11 clinical members. Members represent 13 departments, giving
rise to a total of $4.6M in research grant funding (annual direct costs), of which $3M is peer-reviewed and
$1.7M is NCI-funded. Between 2012 and 2016, GU program members published 802 publications. Cancer and
Program related publications included 20% inter-programmatic, 25% intra-programmatic, 8% inter- and intra-
programmatic and 10% that involved collaborations with another Cancer Center. This highly effective program
has made major practice-changing contributions benefiting cancer patients. Examples include: 1) the discovery
of an abiraterone metabolite, (D4A), a potent androgen receptor inhibitor, leading to clinical studies; 2)
identification of a 17-gene expression that predicts prostate cancer aggressiveness especially for intermediate
Gleason score tumors that has been incorporated into NCCN guidelines for treatment decisions; 3) the
identification of the role of myeloid-derived suppressor cells (MDSCs), PD-L1 and MEK induction in In renal
cancers treated with sunitinib leading to Phase III trials; and 4) the discovery of a gain-of-function missense in
3β-hydroxysteroid dehydrogenase-1 (3βHSD1; (HSD3B1)) leading to multiple confirmatory studies indicating
worse outcomes in men carrying the polymorphism.